California State University San Bernardino MARC

? DESCRIPTION (provided by applicant): The CSUSB MARC program will be an institution-wide effort involving students and faculty in Biology, Chemistry, Psychology and other relevant departments. The goal of this 5-year project is to substantially increase the number of CSUSB undergraduates from underrepresented (UR) groups who graduate and achieve research-based Ph.D. degrees in the biomedical and behavioral sciences. The project will provide a comprehensive, interdisciplinary array of pre-MARC and MARC Trainee activities that will increase the number of motivated students who are able to succeed in rigorous doctoral programs. Project Objectives include: 1) increasing the number of UR students who are well-prepared to pursue baccalaureate degrees in biomedical and behavioral sciences by at least 25%; and 2) increase the number of UR Students who matriculate into biomedical and behavioral doctoral programs at research-intensive universities by 30% in five years. The project is led by a team of seasoned, highly productive CSUSB faculty researchers with proven track records in mentoring UR students toward the doctorate. The proposed CSUSB MARC program will support 6 new MARC trainees each year.

Public health relevance
PUBLIC HEALTH RELEVANCE: The future of the nation's biomedical research workforce depends on the continued development of well-trained undergraduates who seek Ph.D. degrees in the biomedical and behavioral sciences. The next generation of researchers will increasingly be made up of underrepresented students who historically have not pursued such career goals. This project seeks to attract and prepare such students to meet this national need.